Optimization of VesiVax® Lipidated Tucaresol Formulations

? DESCRIPTION (provided by applicant): There is a significant interest and need for developing new immunostimulatory adjuvant molecules that stimulate potent immune responses. To date, the only immunostimulatory adjuvant molecule that has been approved for human use is the Toll-like Receptor (TLR) 4 agonist, monophosphoryl lipid A (MPL). Other immunostimulatory adjuvant molecules such as poly I:C, a synthetic double stranded RNA mimic (TLR3), resiquimod, a synthetic single stranded RNA mimic (TLR7/8) or CpG, a DNA oligonucleotide (TLR9), have been in clinical development for a number of disease indications. A new class of immunostimulatory adjuvant molecules, cyclic dinucleotides (CDNs), have recently been shown to exert potent immunostimulatory properties through activation of an internal receptor called the STimulator of INterferon Genes (STING). In this project, we propose to optimize a small molecule immunostimulatory adjuvant, tucaresol, which we have synthesized with a lipid tail to facilitate formulation in the VesiVax(r) vaccine and adjuvant platform technology. We will synthesize lipidated tucaresol (LT) derivatives and prepare VesiVax(r) LT formulations with a model recombinant protein antigen (i.e., gD3PEPcD-HD) which we have shown to provide protective immune responses in our well-characterized mouse model of intravaginal HSV2 challenge.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project could exert a significant impact on the field of vaccine and adjuvant research by identifying an optimal lipid derivative of tucaresol (LT). This would be highly valuable since the ability to match a particular protein or peptide antigen with an appropriate adjuvant molecule to generate an optimal immune response represents an advance over current strategies for protein or peptide vaccine development. In addition, the fine control o the concentrations of the lipids and LT molecules to be synthesized in this project combined with the ability to manipulate the ratio of these components with a target protein antigen to maximize the immune response cannot be easily achieved with any other adjuvant system. The development of new LT formulations using the VesiVax technology platform is intended to make the development of potent subunit vaccines much easier and hence, will be of great benefit to public health.